TOLERABILITY AND SAFETY STUDY OF LEXIPAFANT IN HIV DEMENTIA

The objective of this study is to assess the tolerability and safety of Lexipafant and to explore its effects on cognitive function, quality of life and activities of daily living.